Improving Neurological Health in Aging via Neuroplasticity-based Computerized Exercise (INHANCE)

PROJECT ABSTRACT
Advancing age is often accompanied by a decline of key neuromodulatory centers of the brain that support adaptive
neuroplasticity. Deterioration of the underlying neurophysiology of the brain predisposes the individual to pathological and
age-related cognitive decline. We propose to deploy a computerized cognitive training program (INHANCE) developed via
two successful SBIR-funded phase II programs (R44AG039965; R44NS071780). The program will combine two previously
validated, but historically independent, exercises that based on prior research may interact to reduce the long-term risk of
dementia onset. We shall conduct a double-blind, parallel-arm, placebo-controlled, randomized clinical trial that will assess
the short- and long-term efficacy of the program to improve neuromodulatory status (via positron-emission tomography)
and neuropsychological outcomes (via standard assessment measures). The broader objectives of the project are two-fold.
One is to address the rapid rise in neurodegenerative disease and the other is to shed light on the underlying neuromodulatory
mechanism(s) through which certain forms of cognitive training achieve neuropsychological improvement. An effective,
low-cost, and highly-scalable program available on the most popular internet-connected devices offers global reach and the
possibility of extending the cognitive health of older adults. With effective computerized tools in hand we can enrich the
lives of patients and their families, alleviate the enormous financial cost associated with minor and major forms of
impairment, and progress swiftly toward the goal of creating a healthier society and a more efficient healthcare system.

Public health relevance
PROJECT NARRATIVE The goal of the current Phase IIB proposal is to evaluate the efficacy of a neuroplasticity-based, computerized cognitive training program—INHANCE (Improving Neurological Health in Aging via Neuroplasticity-based Computerized Exercise)—that trains speed of processing and attentional control in healthy older adults. This web-delivered program aims to improve cognition, as evidenced by standard neuropsychological measures, and plasticity-based cholinergic function as measured through positron-emission tomography. These outcomes are widely applicable to the cognitive health and life- quality of elderly Americans, and have further potential to delay degenerative processes observed in normal aging.